Immunotherapy for Ocular Surface Diseases

ABSTRACT
We have discovered a new mechanism for inflammation on the ocular surface. First, we
discovered the presence of neutrophil extracellular traps (NETs) on the ocular surface of dry eye
disease (DED) patients and subsequently, the presence of citrullinated proteins and anti-
citrullinated protein antibodies (ACPAs). ACPAs not only cause ocular surface disease, but also
stimulate formation of NETs, thus creating a self-perpetuating cycle of chronic inflammation on
the ocular surface. We present an innovative pathophysiological concept: DED is characterized
by breach of self-tolerance towards citrullinated antigens with generation of autoantibodies
(ACPAs) and NETs could represent a source of citrullinated antigens fueling the ACPA
autoimmune response over the ocular surface. We performed a first-in-human pilot clinical trial
and showed that ocular surface immune globulin (OSIG) eye drops, formulated from pooled
human immune globulin products (IVIG), were safe and efficacious in treating DED patients. Our
findings shift the current paradigm that focuses on T-cell mediated inflammation as central to the
pathophysiology of DED to also include autoimmune inflammation that is driven by post-
translational modifications in self-proteins (citrullination) and autoantibodies (ACPAs). The
purpose of this R24 application is to produce preclinical data that supports a commercial
Investigational New Drug (IND) application to the U.S. Food and Drug Administration (FDA). The
longer-term goal is for testing the efficacy of OSIG eye drops in clinical trials and positioning OSIG
eye drops as a new topical biologic immunotherapy for DED patients. Therefore, in Aim A, we
seek to develop an optimum OSIG eye drop formulation using Quality by Design (QbD) principles,
test critical quality attributes (CQAs) and GMP manufacture clinical supplies. In order to use OSIG
ophthalmic formulation in human, an FDA IND is a prerequisite, therefore, in Aim B, we propose
to perform pre-clinical in vitro and in vivo toxicology and efficacy studies using the OSIG
ophthalmic formulation to meet regulatory requirements for IND studies. In Aim C, we propose to
perform a clinical study to identify DED subtypes, clinical presentations and patient characteristics
that are most associated with ACPAs or NETs, hence most likely to show therapeutic benefit with
OSIG therapy. To successfully achieve these three Aims, we have established a highly qualified,
multi-disciplinary team that is experienced in ophthalmic drug development, and FDA processes
and regulations. If the aims of this grant proposal are successfully achieved, we will be one-step
closer to introducing the first immunotherapy for ocular surface diseases into clinical practice.

Public health relevance
PROJECT NARRATIVE We present an innovative pathophysiological concept: Dry Eye Disease (DED) is characterized by breach of self-tolerance towards citrullinated antigens with generation of autoantibodies. Neutrophil Extracellular Traps could represent a source of citrullinated antigens fueling the autoimmune response over the ocular surface, creating a self-perpetuating cycle of chronic inflammation. Because pooled human immune globulins contain anti-idiotypic antibodies that inhibit the pathogenic actions of autoantibodies, we propose to formulate them as eye drops for use as the first topical biologic immunotherapy for DED.